Targeting obesity to improve survival from childhood acute lymphoblastic leukemia

Obesity is a worldwide health challenge that increases the risk of developing and dying from multiple types of
cancer. B-cell acute lymphoblastic leukemia (B-ALL) is the most common childhood cancer. Despite improved
cure rates, children with obesity at diagnosis are more than twice as likely as their lean peers to respond poorly
to induction therapy, and eventually to relapse and die from their disease. Thus, survival for children with obesity
has not improved in lockstep with the broader B-ALL population. Chemotherapy for B-ALL induces many of the
same physiologic changes in non-obese children as those found in the obese, thereby placing even lean children
at risk for chemotherapy resistance. In a series of clinical and laboratory models, chemoresistance in ALL due
to obese physiology was found to be potentially reversible. A recent Phase I trial demonstrated proof-of-principle
that a combination of calorie, fat, and glucose restriction (CFGR), achieved through diet and physical activity,
could reverse obesity-induced chemoresistance. The trial showed that CFGR could be integrated into pediatric
B-ALL induction regimens, and most importantly, that CFGR reduced by ~71% the rate of minimal residual
disease at the end of induction (EOI MRD); EOI MRD is one of the most significant predictors of relapse in B-
ALL. In investigating the mechanisms underlying the efficacy of CFGR, insulin was discovered to be a likely key
initiator of chemoresistance, and adiponectin, an underappreciated hormone countering insulin effects in B-ALL.
The central hypothesis of this proposal is that CFGR will reduce MRD in B-ALL through improving
chemosensitivity by lowering circulating insulin and increasing adiponectin, together reducing signaling
in ALL pro-survival/anti-apoptotic pathways. The long-term goal of this research is to reverse obesity-induced
chemoresistance to improve survival from B-ALL. In this proposal, CFGR efficacy will be evaluated in a
randomized, multicenter Phase II trial conducted through a pediatric leukemia consortium. Lean and obese
enrolled patients with high-risk B-ALL will receive induction chemotherapy with or without CFGR for four weeks.
In Aim 1, patients randomized into strata by obesity status and starting leukemia burden (white blood cell count)
will receive either one-time nutrition and exercise education (control arm) or education plus CFGR (intervention
arm). Primary endpoints will be reductions in MRD and change in fat mass. Secondary endpoints will assess
adherence, fitness, motor function, toxicity, and quality of life. In Aim 2, the contribution of circulating insulin and
adiponectin to obese chemoresistance and CFGR efficacy will be explored. Changes in obese physiology by
CFGR will be assessed via hormones, cytokines, and metabolomics. The opposing effects of obese physiology
and CFGR on intracellular activation of AKT, mTOR, and Raf/Ras chemoresistance pathways will be measured
using mass cytometry. Results from this trial will demonstrate efficacy of CFGR to improve disease response
and provide insight into the mechanisms of obesity-induced chemoresistance in B-ALL, potentially leading to a
paradigm shift in treating this deadly disease.

Public health relevance
Obesity is a major health issue worldwide, and in children with acute lymphoblastic leukemia (ALL), results in a more than two-fold greater risk for resistance to chemotherapy and disease relapse. We propose to test in obese and non-obese children with ALL whether calorie, fat, and glucose restriction (CFGR) achieved by diet and physical activity can improve the response to ALL therapy. Results from this trial may lead to new treatments for ALL and other cancers adversely impacted by obesity.